Metabolic Control of Innate and Adaptive Immunity in Breast Cancer

PROJECT SUMMARY/ABSTRACT
Immunotherapy is a promising approach for treating patients with advanced breast cancer. However,
immunosuppressive microenvironments induced by regulatory T cells (Treg) present a major barrier to
successful anti-tumor immunotherapy. Defining the suppressive mechanisms used by different types of tumor-
infiltrating Treg cells is essential for the development of novel strategies to treat human breast cancer. We
recently discovered high percentages of γδ Treg cells existing among the tumor-infiltrating lymphocytes (TILs)
of breast tumor patients, which are strongly negatively correlated with clinical outcomes. We further identified a
novel suppressive mechanism whereby γδ Treg cells induce senescence in T cells and dendritic cells (DCs)
that then also develop potent suppressive activity. Therefore, it is critical to further identify the molecular
mechanisms responsible for γδ Treg-induced senescence in immune cells, and then to develop strategies to
reverse senescence induction mediated by γδ Treg cells. Increasing evidence indicates that the ability of a
lymphocyte to perform functional immune responses is controlled by pathways of energy metabolism.
However, little is known about the regulation of energy metabolism in tolerogenic DCs and Treg cells. We
recently found that γδ Treg cells dramatically reprogram DC lipid metabolism. In addition, we observed that
TLR8 signaling significantly suppresses glucose metabolism in human γδ Treg cells via inhibition of both
glucose transporters and glycolysis-related enzymes. The central hypotheses of this proposal are that: 1)
breast cancer-derived γδ Treg cells rewrite lipid metabolism in DCs, resulting in DC senescence with
tolerogenic phenotypes and functions; 2) reprogramming of metabolism in Treg cells and DCs can serve as a
novel strategy to synergistically enhance anti-tumor immunity for tumor immunotherapy. Specific Aim 1 seeks
to identify what lipid species are changed in γδ Treg-induced senescent DCs and whether the altered lipid
components are causatively related to the DC senescence and impaired functions. We will then investigate the
importance of transcription factor STAT and PD1-PDL1 signaling in controlling lipid metabolism disorder,
senescence induction and impaired functions occurred in γδ Treg-treated DCs. Specific Aim 2 will identify the
key glucose metabolites that involve γδ Treg-mediated immune suppression and are regulated by TLR8
signaling for functional reversal in human γδ Treg cells. We will then test the novel concept that TLR8
activation in γδ Treg cells combined with checkpoint blockade of PD-L1 in DCs can serve as novel strategies to
reprogram their metabolism and synergistically enhance anti-tumor immunity for breast cancer immunotherapy.
A positive outcome from these studies should lead to novel strategies to reprogram innate and adaptive
immune cell metabolism for future breast cancer immunotherapy.

Public health relevance
PROJECT NARRATIVE The proposed studies address the important areas of breast cancer that is the second leading cause of cancer-related death in women throughout the world, and the regulatory T cell-induced tumor immunosuppressive microenvironment that is a major barrier for successful anti-tumor immunotherapy. The proposed research has relevance to public health, because it seeks to dissect novel suppressive mechanisms and then to develop strategies that control immune suppression mediated by regulatory T cells in human breast cancer. Thus, the findings are ultimately expected to improve treatment of human breast cancer and other cancers as well.